Deciphering the non-canonical function of the histone methyltransferase G9a in the etiology of AD

Abstract
A prominent pathological feature of Alzheimer’s disease (AD) is extracellular accumulation of amyloid-beta
(Aβ) peptides in neuritic plaques that activate microglia/macrophages. Using a quantitative proteomic approach
we identified numerous proteins that showed increased secretion from Aβ-stimulated human monocyte-derived
macrophages/microglia (hMDMs), including our newly characterized neurotoxic protein MMP9 that
recapitulates neuritic tau beading for AD pathology. However, little is known about the AD-causing
mechanisms underlying the translation and secretion of these neurotoxic proteins in Aβ-activated hMDMs.
Clinicopathologic data show that AD onset is directly associated with an increased level of histone H3 lysine 9
dimethylation (H3K9me2) in prefrontal cortex tissue of AD patients. Consistent with this fact, enzymatic
inhibition of the histone methyltransferases G9a that catalyze the increased H3K9me2 rescued synaptic and
cognitive functions in AD mice, implicating constitutively active G9a and G9a-associated pathways in AD
etiology. Our chemoproteomic approach with a biotinylated version of the same G9a inhibitor captured and
identified G9a interactions with the N6-methyladenosine (m6A) RNA methylase METTL3 and other translation
regulatory proteins in both Aβ-stimulated hMDMs and the hippocampus of AD mice. Considering that METTL3
promoted oncogene translation for cancer cell growth, our chemoproteomic discovery from Aβ-stimulated
hMDMs indicated that, in addition to its canonical function in transcriptional silencing of ‘anti-AD’
genes, G9a activates translation of certain neurotoxic genes. Consequently, the objective of this project is
to characterize this new translation regulatory function of G9a in AD etiology. We have found that, in the
hMDMs with prolonged Aβ stimulation, (1) G9a showed a higher enzymatic activity and interacted with
METTL3; (2) mRNAs of AD-related neurotoxic proteins were m6A-modified by METTL3; (3) depletion of G9a or
METTL3 led to similarly reduced overexpression of these proteins, suggesting that G9a and METTL3 both
work in the same translation regulatory pathways; (4) METTL3 is a non-histone substrate of G9a, and
elimination of methylated lysines decreased METTL3 binding to translation initiation factor eIF3 that is
otherwise critical for METTL3-mediated, cap-independent translation. We propose two Aims to test the central
hypothesis that, via Aβ-induced interaction with METTL3, constitutively active G9a activates translation
of certain neurotoxic inflammatory proteins whose secretion promotes AD. We will (1) Determine the
molecular mechanism by which constitutively active G9a and METTL3 cooperate to activate the translation of
Aβ-induced neurotoxic proteins, and (2) Determine how constitutively active G9a promotes METTL3-mediated
translation of Aβ-induced neurotoxic proteins, which, in turn, contributes to AD pathogenesis. We will uncover
this new non-canonical function of G9a in Aβ-induced, METTL3-mediated neurotoxic inflammation, a likely
early-stage pathological mechanism that underlies AD etiology, for early therapeutic intervention of AD.

Public health relevance
Narrative Chronic neuroinflammation provoked by amyloid-beta (Aβ)-activated microglia and macrophages contribute to the etiology of Alzheimer's disease (AD) and can be a pathogenic factor for which early-stage diagnostic markers and treatment targets may be found. Because m6A is the most abundant mRNA modification in gene-specific translation regulation, we will delineate new wide-spread mechanisms that underlie additional, non-histone modifying (epigenetic) functions of G9a in m6A-mediated translation regulation of Aβ-induced neurotoxic inflammation, a potential early-stage pathological mechanism in AD. Our results will provide both new diagnostic/prognostic markers to identify patients with early stage AD and new druggable targets for precision, early intervention of AD.